Discovery of gene function and dissection of network re-wiring in non-model fungi

PROJECT ABSTRACT
The long-term goal of my research program is to be able to make mechanistic models for understudied
fungi, thus allowing us to understand new aspects of fungal biology. To build these models, and predict how
specific perturbations will affect the cell, it critical to have gene function annotations. However, the majority of
the genes in non-model organisms are still unannotated and uncharacterized. Our interest therefore lies in
building and testing computational models for predicting gene function in Candida auris, a newly emerging fungal
pathogen. To carry out this work, we will perform high-throughput transcriptomic studies to generate a co-
expression network, and then test the accuracy of this approach through functional genetic screening and
detailed molecular genetics. As an additional complication to understanding gene function, regulatory network
re-wiring is common throughout evolution, where the same key proteins respond to a suite of different inputs.
Understanding how these signaling cascades can be re-wired will give insight into both gene function and the
environmental stimuli that drive these changes. We will dissect, in molecular detail, the role of cis and trans
factors in network re-wiring between C. albicans and C. auris, using a conserved transcription factor as a case
study. These studies will provide fundamental data and cell biological knowledge to the community studying
fungi, and more broadly to those studying non-model organisms.

Public health relevance
PROJECT NARRATIVE For non-model organisms, a lack of gene information is a significant hinderance to understanding the biology of the organism. We have two complementary research programs to increase our information on gene function in non-model fungal pathogens. 1) to use computational methods to predict gene function, and 2) to use molecular genetics methods to test specific hypotheses about network remodeling in the non-model fungi Candida albicans and Candida auris.